TAXOL WITH RADIOTHERAPY FOR CARCINOMA OF THE CERVIX

Carcinoma of the cervix is the third and most common gynecologic malignancy with over 13,000 new cases in the U.S. each year. Over half will have locally advanced and/or metastatic disease at diagnosis. The best treatment available for these patients is currently radiotherapy. This phase I study will assess the toxicity and efficacy of low dose continuous infusion Taxol and radiotherapy in the treatment of carcinoma of the cervix.